FASEB SRC- The Lipid Droplet Conference: Biology in Health and Diseaseon

Project Summary
The 8th FASEB Summer Research Conference on Lipid Droplets, entitled “Lipid Droplet Biology in Health
and Disease,” will focus on the rapidly developing field of lipid droplet biology. Lipid droplets are dynamic
cellular organelles that play key roles in energy metabolism. Lipid droplet accumulation and dysfunction are
hallmarks of metabolic diseases, including obesity, lipodystrophy, insulin resistance, diabetes, nonalcoholic
fatty liver disease, and cardiovascular disease. Additionally, lipid droplets have been implicated in the
pathogenesis of neurodegeneration and cancer and as organizing hubs for the innate immune response. The
increasing prevalence of metabolic disorders worldwide heightens the urgency to encourage research into
fundamental aspects of how lipid droplets form, grow, move, mature, and degrade; influence cell, tissue, and
organismal physiology; and contribute to disease. Understanding these concepts is necessary designing
appropriate new therapeutic strategies. The conference will be held June 26-July 1, 2022 in Asheville, NC. The
format includes a keynote addresses by both Elina Ikonen and Barbara Kahn, six sessions of talks by invited
speakers, 16 short talks by trainees and early career investigators selected from submitted abstracts, two
poster sessions, a Career-Oriented Workshop on career design and balance, and a Meet the Experts session
on Lipid Droplets in Health and Disease. The meeting format will encourage and facilitate interactions between
trainees, early career investigators, and established investigators. The scientific sessions cover the full breadth
of lipid droplet biology, from biophysical, biochemical, and cellular topics to physiology and disease. Talks from
internationally renowned researchers will span basic to clinical research and describe diverse approaches
(biophysics, genetics, biochemistry, cell biology, physiology) and models (mice, humans, cultured cells, flies,
yeast). This meeting continues to represent the only major international meeting dedicated exclusively to
lipid droplet biology and its relevance to human disease and remains a unique forum for researchers to
exchange ideas and share breaking results in this dynamic and timely field. A central aim of this conference is
training and encouraging the next generation of scientists. This application requests funding to support the
participation of 16 graduate students, postdoctoral fellows, and early career investigators, including women,
underrepresented minorities, and persons with disabilities, who will be chosen from submitted abstracts judged
as superior. The intimate conference format, the secluded conference site, and the many opportunities for
informal interactions between participants, planned and unplanned, will provide young investigators
opportunities to present their work, obtain feedback from leaders in the field, and receive career advice.

Public health relevance
Project Narrative Lipid droplets play key roles in energy metabolism and have been linked to many human diseases, including obesity, type 2 diabetes, non-alcoholic fatty liver disease, atherosclerosis, cancer, and neurodegenerative disorders. A better understanding of fundamental lipid droplet processes is needed to guide the design of rational strategies for the prevention and treatment of these conditions. The 8th FASEB Scientific Research Conference on Lipid Droplet Biology in Health and Disease will bring together researchers of diverse scientific backgrounds and from different career stages to discuss critical issues in lipid droplet biology and to inform and encourage future research by the next generation of scientists.